Public sharing of the Aphasia Recovery Cohort

Project Summary/Abstract The Center for the Study of Aphasia Recovery (C-STAR, P50-DC014664) explores recovery from language impairments following stroke. The center acquires a broad range of magnetic resonance imaging (MRI) modalities as well behavioral measures from stroke patients experiencing language impairments. Like all modern large scale NIH grants, C-STAR has a resource sharing plan that guides dissemination of curated data (following an embargo). However, in addition to this data, the C-STAR team has been acquiring images from people with aphasia using our Siemens 3T MRI scanner since 2006. This trove of data, which we refer to as the `Aphasia Recovery Cohort', or ARC, is the product of both internally supported and NIH funded awards that did not require resource sharing plans and includes data from 250 stroke survivors scanned during 5776 unique sessions. In addition to the imaging sessions, ARC patients participated in numerous treatment and assessment sessions providing a rich range of behavioral measures. The current proposal seeks to curate these data to provide an anonymized public database and search tool (ARCquery). This will allow data scientists from around the world to apply their expertise to this archival dataset, providing new insights into brain function as well as identifying predictors of recovery. This repository will provide a Findable, Accessible, Interoperable, and Re-usable (FAIR) dataset.

Public health relevance
Project Narrative This proposal will create a public repository that includes imaging data, behavioral assessments and demographic data from a group of people with aphasia. This result will be a Findable, Accessible, Interoperable, and Re-usable (FAIR) dataset to help understand the consequences of and recovery from stroke.